Technology Training and Dissemination

ABSTRACT – Technology Training and Dissemination (TTD)
Technology Training and Dissemination (TTD) is an essential part of the Center’s resources, necessary to
facilitate the use of our existing and new technology and software by scientists outside the Center. The goals
of the TTD component are to educate and train researchers to utilize the Center’s resources in their own
research and to disseminate the Center’s virtual imaging tools and resources to the scientific community. To
accomplish these goals, the TTD will implement training and dissemination approaches that meet the diverse
needs of a broad biomedical community, including both novice and specialist users. These approaches will
ensure that a growing community of researchers can effectively use the Center’s resources in their work and
provide feedback that will benefit the Center’s activities. The training plan comprises in-person training through
on-site and off-site workshops, on-site residencies, and ongoing interactions through seminars and scientific
forums. The dissemination plan comprises resources to access the Center’s virtual imaging trial (VIT) tools,
access documentation (user manuals, video guides), obtain support for running and execution, and access
sample code with preconfigured datasets and subcomponents of the VIT tools. Subcomponents include the 3D
and 4D patient models (“virtual patients”) from TRD1, the CT simulation programs (“virtual scanners”) from
TRD2, and the machine learning and task-based analysis tools (“virtual readers”) from TRD3. Software
integration and development will be supported by the Duke Health Technology Solutions (DHTS) office and
managed by two full-time software personnel. The training and dissemination components will be made
available through a website, developed and managed by the Center, which will outline the technological and
educational resources available to the community and information on how to access them. The website will
also be used to collect feedback on existing tools and new desired upgrades from users, which will constantly
help the Center improve its offerings. The research team will leverage its strong ties with other Duke
departments and its rich track record of training and technology dissemination to provide a robust and
comprehensive TTD component to advance the Center’s mission.